Functional Interrogation of Human Acute Myeloid Leukemia Stem Cells

PROJECT SUMMARY
Studies over the last several decades have led to a model that human AML is organized as a cellular hierarchy
initiated and maintained by self-renewing leukemia stem cells (LSCs). The lack of functional studies has limited
the understanding of human AML LSCs and the utility of this stem cell model for translational studies in human
AML. Recently, we have established technical approaches to enable such functional LSC studies in a manner
not previously possible. By employing CRISPR/Cas9 followed by rAAV6-mediated homology directed repair
(HDR), we have successfully conducted genome engineering in primary AML cells that can subsequently engraft
in vivo. Additionally, we have established iPSCs from several primary AML samples that recapitulate
transplantable AML when differentiated into the blood lineage. These AML-iPSCs can be readily engineered
using CRISPR/Cas9/HDR to allow for genomic manipulations including inducible Cre-lox for in vivo leukemia
gene modulation. Our objectives are to interrogate important questions in human AML stem cell biology. (1) We
will investigate the relationship between specific mutations and leukemia stem cell frequency, disease initiation,
and disease maintenance. Specifically, we will correct mutations in primary AML cells and/or AML-iPSCs and
determine the impact on these parameters. (2) The number and dynamics of individual AML stem cells has not
been evaluated at high resolution in vivo. Here, we will investigate in vivo LSC dynamics using methods for single
cell lineage tracing including introduction of sequence barcodes using CRISPR/Cas9/HDR. Additionally, we will
use mitochondrial single cell ATAC-seq as an endogenous barcoding approach to examine these dynamics
directly in patient samples, as well as in xenografted mice and in response to therapy. (3) The primary
translational implication of the leukemia stem cell model is that specific targeting of LSCs, even in the absence
of targeting of non-LSCs, will lead to eradication of AML. This critical concept will be experimentally investigated
by engineering inducible caspase 9 (iCasp9) into the locus for an LSC-specific gene in primary AML cells. Once
established in vivo, iCasp9 will be activated to eliminate the LSCs, and the subsequent effects on the leukemia
will be determined. These studies should facilitate a deeper interrogation of the leukemia stem cell model in AML
and its translational implications.

Public health relevance
PROJECT NARRATIVE Numerous studies have led to a model that human AML is driven by leukemia stem cells (LSCs). However, few functional studies have been conducted in patient cells limiting the utility of this model for translational studies. Our objectives are to use newly developed methods to interrogate important questions including the requirement for specific mutations in disease initiation and maintenance, the dynamics of individual LSCs, and the effect of targeted elimination of LSCs in AML progression.